CHARACTERIZATION OF HUMAN HEMATOPOIETIC CELLS

The goal of this study is to test the hypothesis that CD3+ CD5-T lymphocytes are correlated with the development of graft versus host disease in recipients of allogeneic bone marrow transplants. Uses CDMAS only.